Dermal Lymphatic Transport and Cutaneous Immune Balance

PROJECT SUMMARY
While we have established a tremendous amount of knowledge interrogating intrinsic leukocyte biology to inform
a breadth of immunotherapeutic approaches, more can be done to understand how cutaneous immune
responses are regulated and to translate that understanding into therapies that combat cutaneous immune
imbalance (autoimmunity, chronic inflammation, malignancies). The goal of this proposal is to elucidate
mechanisms of lymphatic transport that contribute to local inflammation and adaptive immune induction to
provide novel insight into how we may tune immune responses in vivo. Our published and preliminary work
establishes the dermal lymphatic vasculature as a necessary route for both immune activation (ON) and immune
resolution (OFF) signals. Further, we have demonstrated that dermal lymphatic vessels remodel their inter-
endothelial junctions (termed ‘zippering’) with functional consequences for pathogen dissemination and immune
induction. Whether these same mechanisms are activated across cutaneous immune phenotypes and how
changes in lymphatic transport directly impact immunity remains unknown. In this proposal we test the
hypothesis that dermal lymphatic vessels exhibit active, context-dependent functional remodeling to coordinate
cutaneous immune surveillance. This hypothesis will be tested along two aims: (1) we will evaluate the crosstalk
between lymphatic transport and the interstitial, inflammatory microenvironment in skin; (2) determine the
functional significance of lymphatic zippering in adaptive immune activation in draining lymph nodes. To
complete these aims, we couple genetic tools with robust immunological assays and high-resolution imaging to
resolve the systems-level interactions between skin and draining lymph nodes in vivo as a function of the
connecting lymphatic vasculature. We propose that lymphatic vessel transport is a poorly understood but active
determinant of cutaneous immune responses and that identification of specific molecular mechanisms that
regulate their function provides novel therapeutic opportunities to tune immunity up or down. Our work will not
only develop our physiological understanding of lymphatic transport and its contribution to immunity but further
suggest novel design principles for how to manage immunological reactions in skin. In this way our work may
help to inform clinical vaccine development and immunotherapy and may identify targets to maintain tolerance
during homeostasis and in response to therapy (e.g. immune checkpoint blockade).

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to determine the physiology and pathophysiology of lymphatic transport following cutaneous challenge and its contribution to cutaneous immune surveillance. Completion of this work may establish lymphatic-dependent design principles for tuning cutaneous immune responses from vaccine development to tolerance and tumor immunotherapy.